Neuronal Regulation of Vascular Development and Maturation in the Retina

PROJECT SUMMARY
Reciprocal interactions among neuronal, glial and vascular-associated cells are critical for proper vascular
development (angiogenesis) and maturation [establishment of the blood-retina barrier (BRB)] in the early
postnatal (P) retina. Although neuronal or glial cell-derived signals that promote angiogenesis and BRB
formation2 are emerging, we do not understand how neuronal synaptic activity, in general, and which specific
neurotransmitter(s), in particular, contribute to these processes. Nor do we know whether neurotransmitters act
directly on endothelial cells (ECs) or indirectly via Müller glia. The superficial vascular plexus develops from
P1-P9 during the spontaneous cholinergic wave. In contrast, the deep vascular plexus development and BRB
maturation (P10-P14) occur at the end of the cholinergic wave and the onset of both spontaneous and
photoreceptor-mediated glutamatergic activity. Transient pharmacological blockade of cholinergic waves
delays deep plexus angiogenesis and BRB maturation; however, the role of extracellular glutamate in these
processes is unknown. In preliminary studies, we have used two mouse strains to assess the effects of
glutamate release on retinal angiogenesis and BRB maturation: a) Vglut1 -/- mice that lack glutamate release in
the synaptic cleft and b) Gnat1-/- mice that constitutively release glutamate in the synapse. We have found that
neuronal activity-dependent glutamate release is a positive regulator of deep plexus angiogenesis and BRB
maturation. These effects are mediated by induction of Norrin in Müller glia and Norrin/b-catenin pathway
activation in ECs. Based on these preliminary data, we hypothesize that extracellular glutamate levels are
sensed by Müller cells, which in turn operate as transducers to induce expression of angiogenic and BRB-
forming factors and promote deep plexus angiogenesis and BRB maturation. We will test this hypothesis in
three aims. First, we will examine how modulation of extracellular glutamate levels [Vglut1-/- mice (no glutamate
release) and Gnat1-/- mice (high glutamate release)] regulates retinal angiogenesis and structural and
functional BRB integrity in the developing retina. We will also examine how glutamatergic and cholinergic
activity interact to regulate these processes. Next, we will test whether Müller cells sense extracellular
glutamate and respond by inducing expression of angiogenic and barriergenic factors. We will examine Müller
cell responses and Norrin expression (an angiogenesis factor) by Müller cells in mice deficient for glutamate
release by neurons or uptake by Müller glia. Finally, we will test if activation of Norrin/b-catenin signalling, that
promotes angiogenesis and BRB maturation, in ECs can rescue deficits of Vglut1-/- mice. Overall, our studies
will provide a novel mechanistic understanding of how glutamatergic synaptic activity regulates development of
the deep vascular plexus and BRB maturation in the developing retina and elucidate how glutamate
excitotoxicity may affect blood vessels in neurodegenerative retinal diseases.

Public health relevance
PROJECT NARRATIVE Although metabolic demand from neuronal function has been shown to regulate vascular development in the retina, a detailed mechanistic understanding of how neuronal activity influences angiogenesis and blood-retinal barrier maturation remains unknown. This project will explore how cholinergic and glutamatergic neuronal activities (separately or in combination) regulate retinal angiogenesis and blood-retinal barrier maturation using genetic, molecular and imaging approaches. The knowledge gathered from this project may be of critical importance to understand the pathophysiology of retinal diseases associated with neurodegeneration and develop novel therapeutic interventions for their treatment.